Ischemia-induced injury to neuronal processes: role of cofilin-actin rod formation

Disability caused by ischemic stroke results not only from neuronal death, but also from injury to axons
and dendrites of surviving neurons. The mechanisms by which ischemia causes injury to these neuronal
processes are not well understood, and have not been well-explored as a therapeutic target. Cofilin-actin
rods are 1:1 linear aggregates of cofilin-1 and actin that form in neuronal processes under conditions of
ATP depletion or oxidant stress. These rods cause degeneration of the neuronal processes in which they
persist. Recent studies demonstrate that cofilin-actin rods form in neurons during and after brain
ischemia, and that their formation can be suppressed genetically and pharmacologically. Here we will
determine the extent to which suppression of rod formation (or accelerated rod dissolution) can promote
neurite survival and improve motor function after stroke. We will use transient and permanent models of
stroke in the mouse to evaluate effects of rod suppression on survival of neuronal processes at specified
intervals after ischemia. We will evaluate the effects of rod suppression on motor impairment and
recovery using a skilled reaching task and other measures of forelimb dexterity. We also aim to better
elucidate the role of inflammation and subcellular mechanisms that drive rod formation and link rod
formation to subsequent neurite degeneration. We will employ subcellular fluorescent probes and real-
time imaging in cell culture preparations to determine why rods form and persist in specific locations of
neurons, and do so even after the ischemic stimuli are removed; whether the persistence of cofilin-actin
rods represent stable aggregates; and whether rod formation influences bioenergetic failure in the
affected neurites.

Public health relevance
Damage to neuronal axons and dendrites contributes to stroke disability. This damage is caused, in part, by formation of cofilin-actin rods in these neuronal processes. Here we will test methods of blocking cofilin-actin rod formation in animal models of stroke, and the effect of these interventions on functional outcome.